Core A: Administrative Core

Core A Project Summary
The Administrative Core of the Senator Paul D. Wellstone Muscular Dystrophy Specialized
Research Center (MDSRC) will coordinate the activities within and outside the Center, as well
as promote an interactive and collaborative research environment. The administrative
responsibilities of Core A include the following: organization of the flow of project information;
distribution of research effort; allocation of budgetary and other resources; preparation of annual
budgets and projections; scheduling and facilitation of monthly Wellstone Neuromuscular
Conference meetings; promotion and coordination of community outreach projects (including
the annual Patient and Family Conference); and consultation with the Dean of the University of
Iowa Carver College of Medicine regarding progress, scientific direction, administrative issues
and concerns, and future plans. The scientific responsibilities of Core A include the following:
integration, coordination, and direction of research projects as needed; consultation with
advisors concerning the importance and progress of Center research relative to other
developments in the area of muscular dystrophy; identification of seminar speakers and
coordination of their participation and contributions to the Center; and hosting of an annual
conference for patients and their families. This Core will also facilitate expansion of our
collaboration with national and international leaders in the field of congenital and limb-girdle
muscular dystrophies, particularly researchers and clinicians at other Wellstone Centers
throughout the United States. The Center Administrator is also responsible for coordinating the
Wellstone Steering Committee Face-to-Face Meeting when this is hosted by the University of
Iowa, coordinating both the patient and family tours and the meetings among Core Directors
and Project Leaders that take place during this event.